Computational Chemical Biology Core

PROJECT SUMMARY
This second phase of the COBRE CBID is designed to 1) provide a world-class environment to provide
researchers access to key techniques relevant to the chemical biology of infectious disease; 2) support and
enable junior faculty to build successful research programs; 3) enhance infectious disease research throughout
the regional scientific community by providing core facility access to all interested researchers. The mission of
the Computational Chemical Biology (CCB) Core is to provide computational resources and expertise to enhance
the productivity of researchers studying infectious diseases.